2nd Panel on Cost-effectiveness in Health and Medicine

DESCRIPTION (provided by applicant): Abstract In 1996, multiple Department of Health and Human Services (DHHS) agencies participated in the roll out of Cost-effectiveness in Health and Medicine. This book recommended standards for the field and proposed a research agenda. In 2010 a group began the process of updating this book. A new panel was constituted, and this New Panel is collaborating with the Original Panel, organized and facilitated by a Leadership Group. Work thus far has been through chapter- and Panel-wide conference calls. A first face-to-face meeting is planned for the Fall. Funding is requested for the final meeting of the New Panel, to be held in the Spring of 2014.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative In 1996, multiple Department of Health and Human Services (DHHS) agencies participated in the roll out of Cost-effectiveness in Health and Medicine. This book recommended standards for the field and proposed a research agenda. An update of this book is underway, and funding is requested for the new panel's final meeting.